Mural stem cells in normal development and germinal matrix hemorrhage in the preterm human brain

PROJECT ABSTRACT/SUMMARY
Brain blood vessel cells play key roles in both physiological and pathological states.
Endothelial and mural cells compose the main structural and functional elements of the
vasculature. Mural cells, which lie outside of endothelial cells, are critical for the development of
the blood brain barrier and regulate blood flow in response to neuronal activity. However, most
studies of brain blood vessels use adult mice and therefore little is known about the developing
vasculature or human brain blood vessels at any age. These knowledge gaps preferentially affect
preterm infants, who are prone to develop hemorrhages specifically located in brain regions called
the ganglionic eminences (GE). These hemorrhages confer high risk for permanent brain injury,
and we have no treatments.
To molecularly define the stages and subtypes of mural cells in the developing human
brain, I developed a Fluorescence Activated Cell Sorting (FACS) strategy followed by single cell
RNA sequencing (scRNAseq). These data revealed distinct stages of mural cell development
from a relatively immature stage at 15GW to the emergence of distinct subtypes at 23 GW.
Strikingly, this strategy also uncovered a novel progenitor population that express both mural and
neural stem cell markers, suggesting a common neurovascular progenitor that contributes to both
angiogenesis and neurogenesis. In the GE, immunohistochemistry with putative neurovascular
progenitor markers revealed these cells in a periventricular and perivascular location situated
amongst canonical neural stem cells. Consistent with these results, FACS-purified mural cells
produce both vascular and neural lineage cells in vitro. In sum, the above experiments lead me
to hypothesize that mural cells contribute to both angiogenesis and neurogenesis during
development and that a predominance of immature stages of mural cells in the GE
contributes to the pathogenesis of hemorrhage. My short-term goals for the proposed K08
are the following: 1. Construct an atlas of human brain mural cells during development using
scRNAseq and postmortem human tissue. 2. Develop organoid, mouse transplant, and CRISPR
tools to manipulate and interrogate the role of specific signaling pathways of mural cells in human
brain development. These results will propel me to an R01. As a physician scientist in Neonatal-
Perinatal Medicine, I am uniquely suited to advance our understanding of brain vascular
development and the application of this knowledge towards future therapy.

Public health relevance
PROJECT NARRATIVE Fundamental questions remain about the origin of brain blood vessel cells and their interactions with the developing neural tissue. This project will define how human brain mural cells contribute to angiogenesis and neurogenesis and build a suite of tools to interrogate specific signaling pathways in mural cells. This knowledge is clinically relevant to dissect how the developing vasculature contributes to brain maturation and specifically to understand a devastating brain hemorrhage that occurs in preterm infants.